Administrative Core

Project Summary/Abstract
The Administrative Core (Core A) will coordinate the scientific activities, facilitate effective communication and
assist with broad data dissemination for the 4 projects and 2 cores. Additionally, it will provide computational and
analytical support for the individual projects, and assist with data sharing amongst projects and cores. The 3
specific aims of the Core are as follows; Specific aim 1. To enable effective communication between project/core
leaders through regular scheduled meetings and symposia. Specific aim 2. To provide bioinformatical and
computational support for all projects. Specific aim 3. To assist the dissemination of generated research amongst
project leaders, the wider scientific community, and lay audiences.